Neurofunctional Differences in Cognitive and Behavioral Impulsivity in Veterans with PTSD

Adverse outcomes, such as aggressive behavior, risk-taking, and suicide, associated with Posttraumatic Stress
Disorder (PTSD) are an ongoing public health concern in Veteran populations. However, PTSD-related impulsive
behavior has only recently become a major clinical research interest. Theoretical models suggest a link between
PTSD and impulsivity. Cognitive neuroscience research indicates that impulsivity can be represented by two
subdomains: cognitive impulsivity (also called choice impulsivity) or elevated sensitivity to immediate
gratification and behavioral impulsivity (also called rapid response impulsivity) or difficulties with behavioral
inhibition. Where cognitive impulsivity is associated with adverse outcomes such as risky sexual behavior and
substance abuse, behavioral impulsivity is associated with violent outbursts and intimate partner violence.
Research suggests that cognitive and behavioral impulsivity may have separate neuropathological origins. For
example, cognitive impulsivity appears to be linked to two neurofunctional abnormalities: 1) an underperforming
self-control network that extends from the dorsolateral prefrontal cortex (dlPFC) to the dorsal striatum and 2)
an oversensitive reward network, which extends from ventromedial prefrontal cortex (vmPFC) to ventral
striatum. On the other hand, behavioral impulsivity appears to be associated with a reduced connectivity within
a right-lateralized inhibitory control pathway that extends from the right frontal region (right inferior frontal
cortex, right dlPFC) and passes through the right temporoparietal region.
Understanding how cognitive and behavioral impulsivity are linked to PTSD may provide a path for uncovering
the different ways impulsivity and its subdomains interact with PTSD-related adverse outcomes in Veterans.
Well validated, fMRI amenable tasks allow for the interrogation of separate cognitive and behavioral impulsivity
neurocircuit systems, which could be utilized to further understand PTSD neuropathology. For example,
temporal discounting (TD) tasks, which examine intertemporal choice between larger later reinforcers and
smaller sooner ones provide a simple yet quantifiable index of cognitive impulsivity. Similarly, go-no-go (GNG)
tasks have been shown to be effective in assessing behavioral impulsivity by examining the frequency of
commission errors (i.e. when a participant responds to no-go stimuli). However, investigations that have
examined the neuroactivation and functional connectivity that underlie PTSD – related impulsivity and its
subdomains in Veteran populations are sparse. Therefore, we aim to 1) use an fMRI TD task to examine the
functional neuroanatomical underpinnings of cognitive impulsivity in Veterans with PTSD and 2) use an fMRI
GNG task to examine the functional neuroanatomical underpinnings of behavioral impulsivity in Veterans with
elevated PTSD levels. Examining PTSD-related impulsivity within the context of broader neural network
dysfunction may lead to the development of novel, neurocircuit based, patient-centered treatments that are
tailored toward malleable cognitive and behavioral impulsivity-related targets linked to adverse health
outcomes for Veterans with PTSD.

Public health relevance
Impulsive behavior is associated with posttraumatic stress disorder (PTSD) in Veterans and is linked to a host of negative outcomes. We aim to examine the impulsivity-PTSD relationship using functional brain imaging and functional connectivity analysis. The importance of this proposed work lies in its potential to lead to the development of new treatments targeting impulsive behavior and its subdomains in Veterans with PTSD.